Adoption and Implementation of the College Alcohol Intervention Matrix (College AIM): Administrative Supplement

PROJECT SUMMARY for ADMINISTRATIVE SUPPLEMENT
This supplement (Administrative Supplements to Promote Research Continuity and Retention of NIH Mentored
Career Development (K) Award Recipients and Scholars; NOT-OD-20-54) accompanies Parent K08AA028543
(PI: Helle) and requests supplementary support in the form of additional research staff to promote the continuity
of research during PI Helle’s time-limited period of leave. The 5-year parent K08 includes career development
training and research aims evaluating the College Alcohol Intervention Matrix (CollegeAIM; NIAAA, 2015a;
2019). CollegeAIM was created to help college campuses select evidence-based alcohol reduction strategies
(EBSs) to implement on their respective campuses. Despite NIAAA prioritization, the availability of the
CollegeAIM tool, and several existing EBSs for risky drinking, relatively little is known about the adoption
and implementation of EBSs for college drinking among stakeholders, and further, to what extent CollegeAIM
is used to identify EBSs for implementation. The parent K08 evaluates the use and effectiveness of
CollegeAIM in the selection of EBSs for college student drinking across a statewide substance use
coalition, with a long-term objective of supporting colleges’ use of CollegeAIM and thus, ultimately the
implementation of EBSs to reduce risky drinking. The project aims are being achieved via a mixed-methods
design to: assess stakeholders’ use and perspectives of the CollegeAIM tool; identify barriers and facilitators to
CollegeAIM use; and identify institution characteristics that impact CollegeAIM use. This is the first study to
extensively evaluate CollegeAIM as a tool to identify EBSs on college campuses and will be instrumental in
developing an organizational decision-support program, intended to be used in tandem with CollegeAIM to
address college drinking. PI Helle is mentored by Drs. Kenneth Sher and Kristin Hawley (University of Missouri)
and an excellent team of collaborators who support PI Helle’s advancement through specialized training in
addictions and implementation science, including mixed-methods design and analytic approaches and alcohol
prevention research. The mentored training is essential to establish PI Helle as an independent investigator in
addiction implementation science and to extend the initiatives of the current study in future R-series proposals.
Supplemental support in the form of salary and equipment for a full-time research specialist is requested to
promote research continuity during the time-limited period of leave. To date, PI Helle’s parent K08 project and
training is on track with the original timeline and the requested supplemental support will ensure continuation of
the K08 timeline. The research specialist will coordinate and continue research activities (e.g., participant
recruitment and enrollment, monitoring ongoing coding protocols) during PI Helle’s leave. This supplement will
both support the parent K08 research and training aims as it will aid in PI Helle’s seamless return to work and
full productivity for all K08 activities (i.e., research and training aims) following leave. These activities will
contribute to PI Helle’s continued advancement as an independent scientist in addiction implementation science.

Public health relevance
PROJECT NARRATIVE of PARENT K08 There are a number of evidence-based strategies to address the serious public health concern of problematic college drinking; yet, the process by which colleges select and implement the strategies is unknown. This project will address this missing link by examining if and how CollegeAIM (a matrix of evidence-based strategies for college drinking developed by NIAAA) is used to by colleges to effectively identify evidence-based strategies that fit the needs of their institutions. This project will result in increased knowledge of what impedes the selection of effective interventions, and will serve as groundwork for the development of support programs to assist colleges in effectively identifying and implementing evidence-based strategies to address risky drinking.